NeuroVirology & Biology Core

PROJECT SUMMARY/ABSTRACT: NeuroVirology and Biology (NVB)
The NeuroVirology and Biology (NVB) core will focus on four major themes underlying NeuroHIV, in line with the
HIV Neurobehavioral Research Center (HNRC) priorities and the OAR scientific agenda: 1) the impact of viral
epigenetics on HIV persistence in the central nervous system (CNS), 2) latent or clinically asymptomatic co-
infections, 3) mitochondrial biogenesis, 4) brain macrophage and astroglial response to systemic mediators of
inflammation and current antiretroviral therapy (ART). The NVB core will continue to enhance the HNRC’s
transdisciplinary focus through close collaborations with the NeuroBehavioral and Psychiatry, NeuroMedical,
Microbiome and Developmental Cores, and utilizing laboratory and analytic techniques specific to CNS-derived
viral and cellular populations in the setting of neurocognitive and other neurobehavioral consequences.
The NVB Core is structured in two complementary units: NeuroVirology Unit and NeuroBiology Unit. These units
will be an integral and indispensable part of the HNRC, and will provide invaluable knowledge and technologies
to enhance research productivity and scientific input to meet the Center’s overall goals and objectives.
· The NeuroVirology Unit will provide expertise and a broad range of validated and clinically relevant
laboratory-based assays with the highest quality and most convenience possible. This Unit has a research
focus on HIV persistence within the CNS and will continue to offer assays to characterize the HIV reservoir
in the brain and in myeloid cells, with a new focus on proviral epigenetics. It will offer cutting-edge sequencing
methods to characterize the epigenetic landscape of the HIV provirus from clinical samples. This Unit will
characterize viral (genotypic and phenotypic), and other factors (co-infections, inflammation, mitochondrial
damage) associated with neurocognitive and other neurobehavioral consequences, such as depression.
· The NeuroBiology Unit will perform state-of-the-art neurobiology and neuropathology analyses of human
brain tissues and in vitro experimental systems, that allow NeuroHIV investigators to understand the cellular
mechanisms associated with mood and neurocognitive disorders. It will analyze the potential neurotoxic
effects of current ART regimens on specific neuroglial cell populations. The NeuroBiology Unit will investigate
the effect of ART and HIV on mitochondrial biogenesis in brains, and in vitro in cultures exposed to ART. In
support of the Center’s expanded focus on depression and depression related factors, this unit will study the
impact of anti-depressant medication on neuronal homeostasis, focusing on markers of autophagy and
associated gatekeepers, e.g. brain immunophilins. The NeuroBiology Unit will incorporate the biomarker
findings from the NeuroMedical Core in the research plans using banked specimens from the CNTN/NNTC.
Finally, the NVB core will continue to provide quality service, implement improved strategic planning processes,
expand its program income system, maintain flexibility to determine offered services, and expand the extensive
number of services already available to HIV investigators.